Flow Cytometery

The Flow Cytometry Core is a new Core that will serve the needs of all Projects in this Program. However, this new Program Core will piggy-back on a well-established Flow Cytometry Core in the Department of Molecular Microbiology and Immunology at the School of Public Health. The history of the existing Core Facility is given below. This Program Grant will provide partial support ofthe Core Director, Dr. Margolick, and Mr. Menendez, an experienced flow cytometer operator in the Core.